Comprehensive Botulinum Characterization via the Bilayer Nanowell Integrated Assay

Project Summary
During this program, Electronic BioSciences, Inc. (EBS) will develop and validate its in-vitro, chip-based, picowell
bilayer integrated assay (BP-IA) for characterizing the complete activity of botulinum toxin serotype A (BoNT/A)
transmembrane toxin. A transmembrane toxin is a molecule that recognizes/targets a specific cell type via
receptor-mediated targeting/endocytosis, forms a pore in the cell membrane, and transports itself or another
molecule into the cell to disrupt cellular function, e.g., botulinum neurotoxin, tetanus, diphtheria, shiga, cholera,
pertussis, etc. While these toxins are innately hazardous to human health, their inherent cell targeting and
enzymatic capabilities can also be harnessed for therapeutic benefit. Today, the emerging therapeutic uses of
toxins include but are not limited to the treatment of muscle spasms, wrinkles, excessive sweating, depression,
anxiety, anorexia, neurodegenerative disorders (e.g., Parkinson’s disease), and targeted cancer therapy.
However, the limitations of current toxin activity assessment methods have constrained the field. There is a need
for a low cost, easy-to-use, rapid, highly sensitive, highly reproducible assay that is capable of individually
quantifying the separate steps of the intoxication mechanism (i.e., the cell targeting/endocytosis and the
intracellular enzymatic activity) to fully understand and utilize toxin functionality. The present standard for toxin
activity assessments is the mouse intraperitoneal injection assay, which has numerous limitations, including
price, variability, time, lack of sample quantification, and the utilization of live animals, in addition relying on a
single endpoint determination that precludes assessment of the toxin’s mechanism. Unknown or poorly
understood differences in the potency (or mode of action) of toxin-containing therapeutics can confound clinical
dose findings, result in over or under dosing patients, and delay (or prohibit) the development and/or availability
of new/novel therapeutics. EBS’ BP-IA technology will be capable of unprecedented toxin characterization in a
low cost, easy-to-use, rapid, highly sensitive, highly reproducible, in vitro, chip-based platform. Furthermore, the
methodology of the BP-IA is customizable such that the complete activity of any transmembrane toxin could be
quantified. The development of the BP-IA under this Phase I program will be accomplished by developing and
building an alpha prototype BP-IA device, and demonstrating the capability of the BP-IA device to quantitatively
assess the potency of commercial BoNT/A therapeutic toxin formulations. Development of the BP-IA, a
technology for which there is no equivalent commercially available and the future gold standard in toxin,
biotherapeutics, cell-targeting, uptake/internal activity, and causation mechanism quantification, will directly
enable the research and development of BoNT/A-based therapeutics, novel toxin agents/samples, the
development of antitoxin agents, the detailed study of toxin and antitoxin mechanisms, the evaluation of the
causative effects of experimental variables on each specific intoxication modality, and the assessment of toxin
potency in general.

Public health relevance
Project Narrative The development of the proposed picowell bilayer integrated assay (PB-IA) will enable more detailed, quantitative, and customizable characterization of transmembrane toxin activity/potency with a methodology that is low cost, easy-to-use, rapid, highly sensitive, and highly reproducible, all on a single, in vitro, chip-based platform. Such technology is presently needed to improve and standardize toxin testing and potency assessments. The PB-IA would greatly assist with improving the scientific understanding of intoxication mechanisms, in addition to aiding with the development, screening, and approval of toxin and antitoxin therapeutics, ultimately resulting in improved human health and patient care, while also aligning with NIH and FDA guidelines for reducing the use of vertebrate animals for assays of biological activity.